Assist-MH digital technologies to support school mental health care

Abstract
Rates of mental, emotional, and behavioral problems among youth are concerningly high, with one in four
reporting a diagnosable disorder during the pandemic and its aftermath. Half of all lifetime mental health
disorders begin by age 14, but on average, services are not received until 8 to 10 years after symptom onset.
Schools are the primary mental health service setting for youth. Therefore, it is more critical than ever to develop
effective, scalable products to support school mental health (SMH) providers as they struggle to meet the ever-
growing mental health needs of students. Digital technologies offer a cost- and time-efficient medium to help
SMH providers optimize their limited in-person time and augment their care to address the clinical needs of as
many youth as possible. The goal of this SBIR is to create Assist-MH, a new interactive digital support system
for SMH providers. The proposed Assist-MH product will offer an innovative suite of SMH supports, including an
interactive treatment planning tool that generates provider-led and student self-paced MH strategies tailored to
the student’s individual needs, along with built-in tools to facilitate monitoring student progress over time. In
Phase I, we will focus on anxiety and depression for 12-to-17-year-old students as this age group has reported
a concerning increase in these MH symptoms in recent years. To guide the development of Assist-MH, we will
conduct stakeholder groups to gather initial input on current challenges and opportunities and specific
recommendations to guide software design and content development. We will use the stakeholder input to
finalize specific strategies and components from the Planning and Admin Centers to be built into the Phase I
fully functioning prototype. MH providers will use the prototype with students they serve over a two-month trial
period. We expect significant improvement in both provider and student outcomes as well as high usability,
feasibility, and value ratings, yielding a positive proof of concept for the full Assist-MH product. Phase I findings
will be used to guide Phase II refinement and expansion. As schools are the primary setting where youth obtain
MH care, Assist-MH offers the potential to provide crucial support to SMH providers in their efforts to address
our nation’s youth mental health crisis.

Public health relevance
Project Narrative Youth mental health rates have nearly doubled over the past several years creating a significant public health crisis. Schools are the primary mental health (MH) service setting for youth, and as prevalence rates have climbed, school mental health (SMH) providers are struggling to meet the needs of the youth they serve. This SBIR will create and test Assist-MH, a new interactive digital support system of innovative treatment planning and intervention tools that will enhance SMH providers’ ability to address the emotional and behavioral health needs of their students more efficiently and effectively.